Distinguishing inflammatory Th17 subsets through using an autoimmune Th17-selective inhibitor

Project Summary
Th17 cells are a subset of IL-17-producing T helper CD4+ T cells and play a pivotal role in the pathogenicity of a
variety of autoimmune diseases, which are affecting over 23 million Americans with no cure. Knowledge about
regulatory mechanisms of Th17 cells might offer new opportunities for treating these diseases. Based on the
requirement of IL-23 for the development, Th17 cells are currently divided into IL-23-independent homeostatic
and IL-23-dependent inflammatory Th17 cells, of which the latter execute both physiological (clearing
extracellular pathogen infections) and pathogenic (eliciting autoimmunity) functions. Substantial efforts have
been made to define gene regulatory networks that discriminate homeostatic and inflammatory Th17 cells.
However, how to dissect the subsets of inflammatory Th17 cells is largely unknown. This knowledge is
critically needed because non-selective suppression of inflammatory Th17 cells, as by the newly approved IL-
23 monoclonal antibody-based therapy for autoimmune diseases, inevitably increases susceptibility to fungal
and bacterial infections. Herein, autoimmune and anti-infection Th17 subsets display differential responses to
the small molecule Clofazimine: the autoimmune effect of Th17 subsets was repressed while the anti-infection
function of Th17 subsets was not disturbed. Our overall objectives in this application are to elucidate the gene
expression and metabolic programs discriminating autoimmune and anti-infection Th17 subsets. The central
hypothesis is that autoimmune and anti-infection Th17 subsets are distinguishable and SHMT1 is a checkpoint
of intracellular serine levels in autoimmune Th17 cells. The rationale for this project is that determination of the
differences between autoimmune and anti-infection Th17 subsets is likely to offer a strong scientific framework
whereby new strategies to autoimmune diseases therapy with substantially increased selectivity and reduced
adverse effects can be developed. The central hypothesis will be tested by pursuing two specific aims: Aim 1)
To identify gene expression signatures of anti-infection and autoimmune Th17 subsets in vivo; and Aim 2) To
determine the role of SHMT1 in regulating intracellular serine in autoimmune Th17 cells. Under Aim 1, single-
cell RNA-seq analysis will be utilized with verification using Cas9-based knockout assay. For Aim 2, the
pathogenicity of autoimmune Th17 cells and their intracellular serine levels will be evaluated in the presence of
SHMT1 modulation: pharmacologic inhibition, genetic knockout, and point mutation with inactive enzymatic
activities. The research proposed in this application is innovative, because it focuses on the regulatory network
discriminating anti-infection and autoimmune Th17 subsets, a heretofore-unexamined mechanism. The
proposed research is significant because it is expected to provide novel opportunities to develop autoimmune
Th17-selective therapeutics for autoimmune diseases. This would be extraordinarily important for patients that
have been infected or exposed to certain pathogens, such as tuberculosis, since existing Th17 inhibitors cannot
be used due to the risks of decreasing the patients’ control of the infection.

Public health relevance
Project Narrative The proposed research is relevant to public health because it will develop a much needed approach to dissect the functions of subtypes of white blood cells called Th17 cells that are involved in the development of autoimmune diseases and clearance of infections. Our central hypothesis is that the subtype of Th17 cells engaged in autoimmune diseases can be distinguished from the Th17 subtype involved in infection clearance, and that understanding this distinction could lead to new, selective treatments for autoimmune disorders without losing the capacity to fight infections, resulting in substantially reduced side effects. Thus, the proposed research is relevant to the NIH’s mission of reducing illness and disability.